Single Molecule Detection of L1 Insertions and Intermediates

Project Summary
Transposable elements are major sources of heritable human genetic variation and can contribute to disease by
causing somatic mutations. This application focuses on the development of genomic tools and technologies to
assess the contributions of these transposons to somatic mosaicism in normal tissues. Specifically, we will
develop tools and technologies to detect variants in long interspersed element-1 (LINE-1, L1) sequences. L1 is
the only active self-propagating protein-coding transposon in humans. We each inherit a distinct complement of
active L1 loci, each of which is typically repressed through methylation of its internal promoter. Here, we propose
to develop single cell mapping approaches to detect de novo L1 insertions and integrate these with long-read
sequencing approaches to reveal the epigenetic status of source elements. We will also pioneer highly innovative
approaches to detect intermediates of the target primed reverse transcription (TPRT) reaction that gives rise to
L1 insertion events. Our multidisciplinary team brings together investigators with expertise in retrotransposon
biology and genetic variation; innovation in the field of epigenetics; and experience with molecular biology and
computational genomics methods development. Our shared goal in this UG3/UH3 project is to provide enabling
tools and technologies to the Somatic Mosaicism across Human Tissues (SMaHT) Network.

Public health relevance
Narrative This project will develop new tools to assess contributions of the LINE-1 (L1) retrotransposon to somatic mosaicism in normal human tissues. Advances here will allow investigators to characterize L1 insertions genome-wide using state-of-the-art long-read and single cell technologies. If successful, the project will enable the Somatic Mosaicism across Human Tissues (SMaHT) Network to develop more complete catalogs of genetic variation in tissues.